Impact of early-life perturbations on pediatric microbiome maturation

ABSTRACT
During the first 3 years of life (YOL) the infant gut microbiome (GM) rapidly diversifies both in structure and
function, concomitant with dietary and environmental transitions. Critically, the GM response to specific external
stimuli is patient-specific, complicating individualized risk predictions. Healthy GM maturation includes accruing
multiple strains of the same species, which frequently differ in key functions. These functional differences, ac-
centuated by horizontal gene transfer (HGT) and de novo mutations, could resolve conflicting associations of
the same species with both health and disease. The rationale behind our proposal is that strain- and species-
level variation in bacterial functions drives heterogenous GM responses to early-life (EL) dietary and antibiotic
perturbations, which explains, in part, individualized developmental trajectories. This proposal pursues two highly
complementary Aims: 1) Define strain-resolved functional maturation of the pediatric gut microbiome and
2) Investigate the acute effects of EL antibiotic (ELA) perturbation on strain dynamics, HGT, and micro-
biome maturation in preterm neonates and microbiota-humanized mice. Aim 1 will test the hypothesis that
EL environmental exposures shape genomic diversification of gut species, causing lasting changes in GM com-
munity structure and microbial functions. We will leverage our unique set of 2,436 stools collected over the first
9 YOL from infants variably exposed to dietary and environmental stimuli. By combining culture-enriched meta-
genomics, metatranscriptomics, and metabolomics, we will determine taxa-function relationships at the sub-spe-
cies level and power statistical models that predict the impact of EL exposures on strain diversification, microbe-
function associations, and transcriptional activity. Aim 2 will test the hypothesis that ELAs acutely alter strain
dynamics and stimulate HGT and that the GM response to ELA can be predicted from baseline composition and
function. Here, we will interrogate 160 stools flanking variable ELA exposure in 80 preterm neonates in the first
4 months of life, combining culture-enriched metagenomics with selective culture and isolate sequencing to char-
acterize the preterm `plasmidome' and profile post-ELA strain dynamics and HGT. To identify microbiome-intrin-
sic responses to ELA, we will utilize an innovative transgenerational mouse model where germ-free dams receive
human, preterm, microbiota that is vertically transferred to their pups, which are treated with parenteral antibiot-
ics. We will use the resulting data to predict individual GM responses to specific antibiotics based on composition,
resistance gene content, and bacterial functions. Our proposal is innovative because our interdisciplinary re-
search team will characterize strain-level bacterial functions to understand the heterogeneity of GM responses
to EL perturbations on two pre-existing sets of human specimens; it is significant because it will identify features
that predict species-resolved GM-specific responses to EL selection. Our work will advance pediatric microbi-
ome research by comprehensively characterizing strain-resolved functional maturation and GM disruption to
understand individual variation leading towards a future of personalized, microbiome medicine.

Public health relevance
PROJECT NARRATIVE The proposed study addresses our gap in understanding how the early life human gut microbiome responds to diet and antibiotics, including impacts on functional maturation and horizontal gene transfer of antibiotic resistance. This research is relevant for public health because it will improve our understanding of the effects of antibiotics and diet on microbiome dynamics beyond the coarse level of microbial communities and establish predictive models for future personalized antibiotic treatment and dietary recommendations that minimize collateral damage and maximize development of the healthy infant microbiome. By complementing data from two unique human cohorts with hypothesis testing in a mouse model this project is relevant to the NIH's mission of leveraging basic research in mechanisms of health and disease to improve outcomes in treatment and maintenance of human health.